The Role of Retroelements in Centromere Function

The essential function of centromeres in chromosome segregation during cell division requires a
complex cascade of epigenetic events involving changes to chromatin character and kinetochore
assembly. Kinetochore formation during mitosis is the culmination of a cycle deﬁned by the “loading”,
or deposition, of newly synthesized CENP-A, a variant histone, into centromeric chromatin. CENP-Atis
faithful assembly during late telophase/early G1 of the cell cycle is facilitated by its histone
chaperone, HJURP. This assembly cascade is sensitive to perturbation by genetic, epigenetic and
environmental insults, with catastrophic consequences for genome/cell stability, but the genomic
elements that guide accurate CENP-A nucleosome assembly are not well understood. A central
conundrum in understanding the genomic features that aQract CENP-A nucleosome assembly is the
observation that established centromeres are replete with satellite DNA while de novo centromeres
(e.g. neocentromeres) lack satellites, yet are deﬁned by retroelements, such as LINE-1s. While it
appears CENP-A nucleosome occupancy may not require speciﬁc DNA sequences, mounting evidence
demonstrates that RNA is a critical component of the epigenetic cascade leading to faithful CENP-A
nucleosome assembly. However, the sequence speciﬁcity, spatiotemporal requirements for and
transcriptional regulation of these centromeric RNAs are currently unknown. In Preliminary Data, we
show that centromeric retroelements (cenTEs) are sites of engaged RNA polymerase and are involved
in the CENP-A assembly cascade at human centromeres, linking a common transcribed genomic feature
to CENP-A assembly at both native and de novo centromeres in humans for the ﬁrst time. Leveraging our
expertise in centromere assembly, noncoding RNAs, chromosome engineering, and genomics, we have
formulated three aims, each with an innovative approach that will allow us to provide an unbiased
assessment of where within centromeres transcription initiates, when during the cell cycle transcript
initiation and elongation occur, and how these transcripts mediate centromere nucleosome assembly. We
will use chromosome engineering to directly test whether cenTEs and their transcriptional activity
are suﬃcient to facilitate de novo centromere assembly on chromosomes. These engineered chromosomes
provide a new model to study the processes guiding cenTE-mediated centromere assembly and
stabilization, and to examine misregulated incorporation of centromeric histones. The outcomes of
this study will ﬁll a large gap in our current understanding of centromere assembly and maintenance
in normal cells, and provide valuable insight into events underlying chromosome aberration presenting
in human diseases, infertility, and cancers of high metastatic potential.

Public health relevance
Centromeres are the site of kinetochore assembly and spindle attachment during meiosis and mitosis. Thus, the proper functioning of centromeres is a prerequisite for faithful segregation of chromosomes, the lack of which is fundamental in cancer, infertility and genomic instability in a broad spectrum of human diseases. This work aims to understand the role that transcription of centromeric retroelements plays in centromere function.